STORE CHEMICALS AND DRUGS USED IN CANCER CHEMOTHERAPY

The principal objectives of the project are the receipt, storage, inventory, distribution, documentation, and control ofsynthetic compounds crystalline natural products and bulk clinical drugs.